ECHO Administrative Supplement - Coordinating Center

The ECHO Biorepository serves as a national resource responsible for acquiring, storing and
distributing ECHO specimens. The biorepository maintains quality by using standardized
processes and procedures and provides a secure environment and necessary systems to
receive, maintain, and distribute the ECHO specimens to approved parties. The biorepository
provides management of all ECHO specimens. The ECHO specimens consist of existing
collections located at a site’s local storage that sites will transfer to the biorepository and new
specimens collected under the ECHO-wide Cohort Data Collection Protocol and sent directly to
the biorepository. Some biospecimens to be stored in ECHO Biorepository were collected over
many years from studies and are available in a finite quantity. Each ECHO biospecimen is
unique and cannot be replaced if lost, damaged, or contaminated. It is very important that these
biospecimens be stored under optimal conditions, which vary from type to type of biospecimen.

Public health relevance
Narrative Biospecimens collected under the ECHO-wide Cohort Data Collection Protocol will be stored in the ECHO physical biorepository. Fisher Bioservices will continue to serve as the biorepository vendor for the ECHO Program. They will be responsible for providing specimen collection kits and acquiring, processing, storing, and distributing ECHO biospecimens.